Administrative Supplement to Purchase Thermocycler Instruments

Administrative Supplement to Purchase Thermocycler Instruments
ABSTRACT
This supplement requests replacement of thermocycler equipment to support research funded through
NIGMS grant R35 GM122532 (PI: Weeks). Our research program is focused on using genomics methods to
understand the structure, function and ligandability of RNA secondary and tertiary structures. Methods and
technologies invented in our laboratory are extensively adopted by research labs and biotechnology
companies worldwide. RNA genomics methods ultimately all rely on massively parallel sequencing for their
readout, and library preparation for sequencing requires multiple PCR or RT-PCR steps. Two of our
thermocyclers have recently broken and are unrepairable, severely compromising our workflow.
Procurement of these replacement instruments is essential to accomplish the core aims of the parent
project, will accelerate biomedical research, and will enhance sustained biomedical impact by the Weeks
laboratory.

Public health relevance
Administrative Supplement to Purchase Thermocycler Instruments Summary of Parent Grant RNA functions as the central conduit of information exchange in all cells. RNA molecules encode this information in both their primary sequences and in complex structures that form when RNA folds back on itself. The broad and fundamental importance of RNA structure is clear, but there remains a profound knowledge gap: We generally have only rudimentary understanding of RNA structure across vast regions of most messenger and non-coding RNAs. We need to move beyond modeling RNA structure to directly detecting through-space structural communication and interactions in cells. In essentially every instance where we have applied rigorous and quantitative technologies to study RNA structure-function interrelationships, new insights regarding biological regulatory mechanisms have emerged. We have also shown that RNA elements with higher-order structures are more likely to contain high-information-content clefts and pockets that bind small molecules, broadly informing a vigorous field of RNA-targeted drug discovery. Our work has sustained long-term impact due to pursuing three overarching opportunities. First, the project focuses on development of decisive, concise, and broadly implementable technologies for discovering and assessing higher-order structure in RNA. Second, this project applies these direct and experimentally concise methods to challenges of broad importance, from identification of structures essential for replication of pathogenic viruses to understanding how RNA conformational ensembles govern transcriptional gene regulation and pre-mRNA splicing. Third, understanding the propensity of RNA to form higher-order structures – and often clefts and pockets – opens up the possibility of targeting these motifs with small molecules, an opportunity we will exploit with the long-term goal of inventing facile and straightforward strategies for creating RNA-targeted therapeutics. Overview of Need for Equipment Purchase This administrative supplement requests funds to purchase and replace thermocycler instruments to be used by the Weeks research laboratory, which is currently supported by NIGMS R35 GM122532 (Dr. Michael Sakalian, PO). The cost of the essential instruments is $19,999.98 and is outside the range of equipment that can be purchased in the context of the current budget. Our grant budget is fully encumbered, and will zero out, for the next year. The requested instrument will be shared and used by multiple members of the Weeks group. The need for replacement thermocyclers was unforeseen at the time of the original research proposal. Thermocyclers are essential for all modern RNA genomics experiments. Our current, non-functional instruments were purchased in 2012, twelve years ago. Stuff breaks, and we absolutely need to replace these instruments to do our MIRA-funded work. We need two instruments due to the volume of work and sequencing that we do. Diverse researchers will benefit from this purchase. The thermocycler instruments will be used by all Weeks group members, from undergraduates to postdocs (14 total). The simple operating design and user interface of the requested instruments will allow all members of the lab to use the instruments efficiently. Plan for training and upkeep. The instruments will be maintained by the Weeks lab. A lead user in our laboratory will be assigned and will facilitate training and ensure the instruments operate efficiently.